Medical Scientist Training at UMMS

PROJECT SUMMARY
The MD/PhD (MSTP) Training Program at the University of Massachusetts Medical School (UMMS)
demonstrates excellence and firm commitment of UMMS to train the next generation of physician scientists.
This program is in alignment with the goals of NIH and the UMMS mission to be a leader in clinical and
translational science training. The UMMS MD/PhD education integrates the curricula of the Medical School and
the Graduate School of Biomedical Sciences (GSBS) with program-specific elements to train outstanding
physician scientists for careers in academic medicine, biomedical and clinical population health sciences
research. Our integrated program accelerates students' progress by eliminating traditional core lecture
requirements, maximizing student exposure through research rotations and individual tutorials, providing
flexibility and a comprehensive education in state-of-the-art research approaches and clinical disciplines. With
the help of MSTP support, UMMS provides full funding for the program, including tuition waivers, annual
stipends and fees, health, dental and disability insurance, which is a strong indicator of the commitment of the
institutional leadership to training physician-scientists. Strengths of our program include outstanding basic
science faculty, supportive institutional infrastructure, investment into translational sciences, expertise in the
Quantitative Health Sciences Department, and a strong tertiary-care academic medical center that serves
central Massachusetts. The 81 students currently in the program participate in the full spectrum of clinical and
translational science training including thesis research in Basic Biomedical Sciences or Clinical Population
Health Research. Our graduating students have remarkable publication records and preparedness for
becoming independent scientist or lead in teams, rank in competitive residency and fellowship programs and
advance medicine through new scientific discoveries.

Public health relevance
PROJECT NARRATIVE The MD/PhD Training Program at the University of Massachusetts Medical School (UMMS) incorporates a dynamic training environment and an integrated curriculum in medicine and research innovations to educate and train the next generation of physician scientists. Outstanding students are selected for the program who after graduation continue careers in academic medicine, research and academic leadership positions to advance medical sciences and health care.